Immune regulation and gastrointestinal co-morbidity in autism spectrum disorders

Project Summary/Abstract: Autism spectrum disorders (ASD) are behaviorally defined and affects 1
in 68 children in the United States; however, little is known about its etiology and pathophysiology.
Interestingly, over half of children with Autism Spectrum Disorders (ASD) have co-morbid gastrointestinal (GI)
symptoms. GI problems occur 6-8 times more frequently in ASD than in typically developing (TD) children and
are associated with more exacerbated behavioral impairments. Although Very little is known about the
pathophysiological pathways underlying GI problems in ASD. Increased immune activation, pro-inflammatory
cytokine production and autoantibodies directed to gut epithelium have been reported in children with ASD and
GI symptoms. Regulatory T cells (Tregs) are key mediators of peripheral tolerance that maintain their lineage
commitment and function through epigenetic regulation and prevent inappropriate mucosal inflammation in
response to bacteria and other luminal antigens/components. We and others have previously demonstrated
decreased blood levels of the immunosuppressive and Tregs-associated cytokines transforming growth factor
(TGF)β1 and interleukin (IL)-10, fewer putative Tregs and alterations in epigenetic mechanisms in children with
ASD. Our new preliminary data shows that these immune regulatory deficits are more severe in children with
ASD and persistent GI symptoms. In animal models with face and construct validity to ASD, defects in GI
barrier integrity and decreases in Tregs were observed. However, no studies have yet addressed the functional
cellular mechanisms of Tregs in ASD or preclinical models of ASD. We will test the innovative hypothesis that
deficits in the ability to control immune responses by Tregs are an underlying pathophysiological mechanism in
children with ASD who experience GI co-morbidities. This is an important area of investigation since
therapeutic targeting of immune control mechanisms might improve GI barrier integrity and alleviate behavioral
abnormalities. Parallel clinical and preclinical experiments will be performed to investigate this hypothesis. The
proposed studies will determine Treg cellular function (Aim #1) and epigenetic mechanisms controlling Treg
commitment and stability (Aim #2) in both children with ASD and TD controls with and without GI symptoms.
This proposal will directly assess specific cellular mechanisms with potential for novel therapies. One of these
therapeutic approaches, adoptive transfer of Tregs, will be utilized to rescue GI barrier integrity and behavioral
impairments present in a preclinical mouse model that exhibits many ASD-relevant features (Aim #3). If
successful, this research will validate the transformative concept that ASD is, for some, a disorder due to
defects in immune regulation and control by Tregs, and will validate a novel mechanism for one of the most
visible public health concerns of our time.

Public health relevance
Project narrative: Autism spectrum disorders (ASD) are pervasive and prevalent neurodevelopmental disorders with over half experiencing co-morbid gastrointestinal (GI) symptoms; however, little is known about the pathophysiological pathways underlying GI problems in ASD, which associate with a more affected behavioral phenotype. We propose that there is a defect in immune control by regulatory T cells (Tregs) in children with ASD and GI symptoms that impacts behavior. This hypothesis-driven project will challenge current paradigms and address a major gap in ASD research by providing critical information on the consequences of immune dysfunction in children with ASD with GI symptoms, including translating targeted cellular mechanisms for therapeutic intervention into a functional model.